Human circadian, sleep, cardiovascular and neurobehavioral responses to light

DESCRIPTION (provided by applicant): The purpose of this proposal is two-fold: (1) to provide protected time and support to Dr. Klerman while she mentors graduate students, post-doctoral fellows and junior faculty towards careers in patient-oriented research; and (2) to conduct patient-oriented research related to the effects of light on multiple physiologic functions. Dr. Klerman is actively involved in both patient-oriented experimental work and mathematical analyses and modeling that will enable translation of research results into real-world applications. The mammalian eye serves both visual and non-image-forming functions. Some of the non-visual responses are due to the effect of light on circadian rhythms, the endogenous ~24-hour rhythms generated by a pacemaker in the hypothalamic suprachiasmatic nucleus (SCN). Disruption of the circadian pacemaker or of its normal phase relationship with local time, such as with night or rotating work shifts or jet lag, is associated with illness, errors and accidents. Other non-visual effects of ocular light exposure include melatonin suppression (as a signal for seasonal reproductive changes), pupillary reflexes, and changes in heart rate, performance, and alertness. The SCN receives ocular light stimuli primarily mediated by intrinsically photosensitive retinal ganglion cells, rather than rod and cone photoreceptors. The outputs of the SCN influence almost every physiologic function, including the timing and content of sleep, hormone release, cardiovascular and gastrointestinal function, objective performance, subjective alertness, and mood. We will quantify the effects of light on circadian rhythms and other physiologic functions using experimental, modeling, and database approaches. Experimentally, we will document the effects of short duration light stimuli and the duration of darkness exposure required to reset circadian sensitivity. The data from these experiments will be combined into a database with data from over 2000 subjects already studied in similar protocols. All these data then will be used to refine our validated mathematical model of the effects of light on the human circadian pacemaker. This model and a linked model of circadian and sleep-wake schedule effects on performance and alertness with countermeasure applications will be made available on the internet. The activities outlined in this proposal have implications for science, for public health, and operational (work) situations. The mentoring work will address a critical shortage of researchers in sleep and circadian rhythms, documented in a US Department of Health and Human Services-sponsored National Center on Sleep Disorders Research report. The experimental work is relevant both for understanding the basic physiology of human circadian, hormone, heart rate, performance and alertness functions and for patient-oriented research including retinal/eye care and sleep of older persons. The results can be used to make predictions about the effects of light, to make recommendations involving exposure to or avoidance of light, and to design environmental lighting, resulting in improved health and alertness and decreased errors and accidents.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of this proposal is two-fold: (1) to provide protected time and support to Dr. Klerman as she continues mentoring graduate students, post-doctoral fellows and junior faculty towards careers in patient- oriented research; and (2) to quantify the effects of short light stimuli on human circadian rhythms, performance, alertness, and other physiologic functions. Narrative The purpose of this proposal is two-fold: (1) to provide protected time and support to Dr. Klerman as she continues mentoring graduate students, post-doctoral fellows and junior faculty towards careers in patient- oriented research; and (2) to quantify the effects of short light stimuli on human circadian rhythms, performance, alertness, and other physiologic functions. __SpecificAimsTextDelimiter__ Specific Aims The mammalian eye serves both visual and non-image-forming functions. Until recently, clinical and research attention has focused on visual function. However, new work on the anatomy and physiology of the non-image- forming responses have revealed their influences on multiple physiologic functions, some of which have significant effects on health and safety (public health). Some of these effects are due to the effect of ocular light exposure on circadian rhythms, the endogenous ~24-hour rhythms generated by a pacemaker in the suprachiasmatic nucleus (SCN) of the mammalian hypothalamus. Disruption of this circadian pacemaker from its normal phase relationship with local environmental time, such as occurs with night or shift work or jet lag, is associated with illness, errors and accidents. The outputs of the SCN influence almost every physiologic function, including the timing and content of sleep, hormone release, cardiovascular, reproductive and gastrointestinal function, neurocognitive objective performance, subjective alertness, and mood. The SCN receives ocular light stimuli primarily mediated by intrinsically photosensitive retinal ganglion cells (ipRGCs), non-visual photoreceptors in the mammalian eye, rather than rods and cones. Other non-visual effects of ocular light exposure include melatonin suppression (and thereby seasonal reproduction and other functions in some mammals), pupillary reflexes, and changes in heart rate, performance, alertness, mood, and sleep. Because light is the most potent stimulus for these functions, it is important to understand what characteristics of light are most effective. Multiple studies have documented the importance of timing, duration, intensity and wavelength of light on these responses. We have preliminary evidence that at short stimulus durations, the classical cone photoreceptors are more sensitive to light, while at longer stimulus durations, the melanopsin containing ipRGCs are more sensitive. One goal of the proposed work is to complete a dose response curve for the duration of light on the human circadian pacemaker using experimental, modeling and database approaches. Experimentally, we will quantify the effects of ocular light stimuli of 2 and 12 minute durations - stimuli that were previously considered too short to have an effect, but may induce significant physiologic changes. We will also investigate the duration of darkness exposure required to reset circadian sensitivity after adaptation to light stimuli. The effects of light on other physiologic functions, including melatonin suppression, heart rate, performance and alertness will also be studied. The data from these experiments will be added into a study database with data from over 2000 subjects already studied in similar protocols in the same facility on the effects of different light duration, intensity, timing and wavelength on the human circadian pacemaker, melatonin suppression, heart rate, cognitive performance, alertness, mood, and sleep. All these data will be used to amend our current validated mathematical model of the effects of light on the human circadian pacemaker, and a linked model of circadian and sleep-wake schedule effects on performance and alertness, so that they can be used for more accurate predictions for the design of light as a potential countermeasure to alleviate symptoms of circadian misalignment encountered during night or rotating shift work and jet lag. This work therefore has the potential to impact the health and safety of ~100 million people per year working night or rotating shifts and ~156 million people flying across multiple time zones. Dr. Klerman's mentoring of patient-oriented researchers and the experimental work will yield both basic (better understanding of the basic physiology of the human circadian, hormone, heart rate, performance and alertness functions to ocular light stimuli of different duration) and clinical (e.g., retinal/eye care) outcomes. The applications of this work also include making predictions about the effects of light on physiology, making recommendations involving exposure to or avoidance of light, and designing environmental lighting (e.g., in room or desk lights). The result should be improved health and alertness and decreased errors and accidents. Therefore, our specific aims are: 1) To test the hypothesis that very short (2 minute) ocular light exposures have a significant effect on the human circadian system as well as on hormones, heart rate, neurocognitive performance and alertness. 2) To test the hypothesis that 36 minutes of darkness are sufficient to reset the circadian system's responsiveness to ocular light exposure. 3) To expand a database using data from ~2000 completed studies of the effects of light on the human circadian pacemaker, hormones, heart rate, neurocognitive performance, alertness, and sleep. 4) To update a validated mathematical model of the effects of light on the human circadian pacemaker with information from the experimental work and the expanded study database, and to make it available for general use on the internet or by request. 5) To provide support for Dr. Klerman's mentoring activities in patient-oriented research.